Synthetically Accessible Virtual Inventory (SAVI)

The Synthetically Accessible Virtual Inventory (SAVI) comprises a huge molecule collection. LHASA transform rules, originally intended for retro-synthetic analysis, were applied to Enamine Building Blocks in a forward synthetic manner. Adding new transforms, expressly developed for SAVI, resulted in SAVI-Lib-2020, a collection of more than a billion synthetically accessible compounds. Handling a billion molecules explicitly is computationally quite demanding for drug discovery applications. SAVI-Space-2024 was created to address this shortcoming. We recently described the design and implementation of SAVI-Space-2024. We emphasized its reaction-driven combinatorial data structure that encodes transformation rules as reaction SMARTS and applies them in a combinatorial manner. Based on Enamine Building Blocks, this approach yields 7.5 billion molecules while requiring only a fraction of the memory (1.4 GB compared to 210 GB). Furthermore, the improved search capabilities - including fast similarity and substructure searches and docking applications on standard hardware - represent a significant advance over the enumerated SAVI library.